Disease Severity Stratification in Multiple Sulfatase Deficiency

PROJECT SUMMARY
Multiple sulfatase deficiency (MSD) is an ultra-rare, multi-systemic, progressive neurodegenerative
disorder. Median age at death is 13 years, and there are no approved disease modifying therapies. MSD
arises from pathogenic variants in SUMF1, which encodes the formylglycine generating enzyme (FGE).
Because of the necessary activation of all sulfatases by FGE, patients with MSD suffer from the
combinatorial effect of decreased sulfatase activity. Some of these sulfatases are associated with well-
described monogenic disorders including 5 subtypes of mucopolysaccharidosis (MPS) and metachromatic
leukodystrophy (MLD). Overall, the signs and symptoms of MSD are progressive, although the specific
features can be variable. Despite the active development of therapeutic options in preclinical models,
robust, quantitative markers of MSD progression and severity are lacking. We hypothesize that a
disease-specific scale and novel glycosaminoglycan biomarkers will capture symptom burden and
disease severity in MSD.
There are several active preclinical research programs focused on developing novel MSD
treatments. AAV9-based gene therapy improves biochemical markers of disease and prolongs survival in
mouse models of MSD. To prepare for future clinical trials, we have enrolled more than 30 patients into our
MSD natural history study and biobank. Our preliminary analysis of this dataset revealed key phenotypic
features, such as loss of motor and feeding skills, that appear to correlate with disease progression and
genotype. In Aim 1 of this proposal, we will build upon our prior work to develop a quantitative outcome
measure that captures meaningful clinical symptom progression in MSD. We will iteratively test this tool in our
retrospective MSD cohort and validate it prospectively. We plan to use this novel MSD scale to measure
longitudinal change, stratify patients, and determine inclusion/exclusion criteria in upcoming clinical trials.
Through analysis of clinical records, we found that patients can be divided into severe and attenuated
subgroups based on attainment of ambulation. While this is helpful with retrospective analysis, determining
subject classification may be difficult in newly-diagnosed patients, who are often infants. There is no
established biomarker that can differentiate MSD subgroups. In Aim 2, we will investigate if the nonreducing
end species of glycosaminoglycans (GAG-NREs), unique oligosaccharides that accumulate in MSD,
correlate with disease severity. GAG-NREs are well-validated biomarkers in a number of related MPS
disorders. We anticipate that overall GAG-NRE species will be elevated in MSD patients, and that the
magnitude of elevation will be proportional to clinical severity. Collectively, the MSD disease scale and
biomarkers developed here will be essential to clinical trial design as we prepare to move promising
preclinical programs into first-in-human trials.

Public health relevance
PROJECT NARRATIVE Multiple sulfatase deficiency (MSD), is an ultra-rare progressive, lethal neurometabolic disorder with no FDA- approved therapy. While preclinical models of MSD respond to AAV-mediated gene therapy in the laboratory setting, validated measures of disease severity and progression are needed before human trials can be begin. In the proposed work, we will use our natural history cohort to develop tools for use in future clinical trials: a MSD clinical severity scale and a novel biomarker of disease.